MORTALITY OF HISPANIC POPULATION IN THE UNITED STATES

The mortality of the Hispanic population of the U.S. has been little studied, but the few completed studies have reported distinct differences in causes and rates of mortality between Hispanics and Anglo-Americans. Past studies have been limited by problems of identification of the Hispanic population and by a lack of adequate broadly geographic data. Recent developments have greatly increased the availability and reliability of data on Hispanics. Data from the NCHS for selected places of birth are for the first time available for all decendents, and most states with large Hispanic populations are now recording ethnic origin information on death records. This study proposes to analyze these as yet unused new data sources to establish mortality rates for the 1980 census period for those of Mexican, Puerto Rican and Cuban birth throughout the U.S. and for Mexicans, Puerto Ricans, and Cubans, who are living in major areas of Hispanic population concentration regardless of generation in the U.S. These rates will then be compared with those of Anglo-Americans to establish differential mortality, with particular attention to the relatively low reported mortality among Hispanics aged. The mortality rates of first and later generation Hispanic immigrants will also be compared to examine intergenerational mortality differentials. Mortality rates derived will be age- and sex-specific for leading causes of death.